SCIOME - SPECIALIZED TECHNICAL AND SCIENTIFIC SERVICE

Much of the outward impact of the Biostatistics and Computational Biology Branch's (BCBB) methods development is through external use of our software and databases, which require maintenance and updates. . Such efforts can be intractable for tools written by trainees with brief tenures. Developing, maintaining, and updating software is a labor-intensive, but readily delegated task. This contract will support consulting in the development and implementation of biostatistics and computational biology tools for BCBB investigators.